Data Management Core

Summary/Abstract:
The Data Management and Analysis Core (DMAC) will provide the Yale Superfund Research Program
(YSRTP) with a state of the art data management, bioinformatics and environmental statistics infrastructure that
will serve as a focal point for integrated data management and analytics across YSRTP projects and cores. The
proposed YSRTP research projects will yield a significant amount of data with a range of types and features that
will require a robust data management component, systematic bioinformatics analyses for various omics data,
and sophisticated statistical analyses including but not limited to methods for spatially and spatiotemporally
correlated data, high dimensionality, large datasets, and missingness (e.g., limits of detection). Thus, DMAC will
be critical to the functioning of the YSRTP and leverages the expertise from the Yale School of Public Health
Department of Biostatistics and its Division of Health Informatics along with value-added expertise provided by
their affiliated centers: Yale Center for Analytical Sciences, Yale Center for Medical Informatics and Yale Center
for Statistical Genomics and Proteomics. Given these resources, DMAC will provide ready access to well-
qualified, experienced clinical informaticians, biostatisticians and bioinformaticians who have previously
established, successful collaborations with many of the investigators in the YSRTP. The expertise provided will
include a full spectrum of consultations with PhD-level faculty for data capture and management, and design and
analysis of projects. DMAC will manage the data flow within and beyond this YSRTP program and will work
closely with all cores and project scientists to integrate the data from all projects to develop and test scientific
hypotheses. DMAC will also serve as a hub for providing feedback to project scientists to drive further scientific
investigations and innovation to advance the aims and objectives of the YSRTP. To achieve these objectives,
DAMC will focus on three specific aims: Aim 1: Coordination with Projects and Cores; Aim 2: Fostering Data
Sharing and Interoperability and Aim 3: Data Quality Assurance, Quality Control and Data Integration.
Achievement of these aims and objectives promises to significantly accelerate the overall objective of the YSRTP
to foster and conduct research that improves the detection, toxicological evaluation, risk assessment, mitigation
and forecasting of emerging contaminants in drinking water.

Public health relevance
Project Narrative: On behalf of the Yale Superfund Research Training Program (YSRTP), the Data Management and Analysis Core (DMAC) will provide the YSRTP with a state of the art data management, bioinformatics and environmental statistics infrastructure that will serve as a focal point for integrated data management and analytics across YSRTP projects and cores. DMAC will also serve as a hub for providing feedback to project scientists to drive further scientific investigations and innovation to advance the aims and objectives of the YSRTP.